Intramural Training of NIBIB Researchers

Intramural training programs being supported this year include: (1) Imaging Sciences Training Program (ISTP) NIBIB Radiology Fellows in collaboration with the NIH Clinical Center; (2) National Institutes of Health NIBIB/NIST National Research Council Fellows in collaboration with the National Institute of Standards and Technology; (3) The Center for Devices and Radiological Health/NIBIB Fellows in collaboration with the Food and Drug Administration (FDA); and (4) the NIH/NIBIB Bioengineering Summer Internship Program (BESIP). These programs train scientists from the post-baccalaureate to the post-doctoral levels.